Core A: Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The overall goal of the proposed Rush ADRC is to create an inter-disciplinary environment that supports
innovative research on etiology, pathogenesis, diagnosis, treatment, and prevention of Alzheimer’s dementia
and related dementias (AD/ADRD). The Administrative (Admin) Core will exercise overall scientific leadership
of the Rush ADRC to set the overall direction of the Rush ADRC, ensure optimal utilization of Rush ADRC
resources, promote the implementation of the ADRD NAPA milestones, and serve as a resource for other
aging and AD/ADRD activities at the national and local level. It will 1) ensure that each of the other Cores, and
trainees reach their goals and greatest potential by establishing effective communication and interaction
through the Executive Committee; 2) guide the use of institutional resources for the ADRC; 3) support a user-
friendly mechanism to facilitate the use of Rush ADRC resources by the wider aging and AD/ADRD research
community, locally, nationally, and internationally, through the Resource Distribution Committee; 4) identify and
support high quality development projects and Rush ADRC Research Scholars; 5) ensure active and
constructive participation in collaborative efforts with other organizations, advance research and knowledge of
AD/ADRD, including RUMC, NIA ADRCs and other efforts; 6) monitor achievements and modify goals and
future directions through the External Advisory Committee.
These aims are supported through the careful design and integration of the Administrative Core with the other
seven Cores and Research Education Component that comprise the Rush ADRC. The Rush ADRC addresses
many of the NAPA Milestones including: 1) population studies via 3 community-based cohort studies and two
affiliated cohort studies funded as R01s conducted by Rush ADRC investigators that are all harmonized to the
ROS Core. They include multi-level, multi-region omic data for precision medicine and health equity as two
cohorts are exclusively of Blacks and one of Latino and the two other studies are predominantly non-Latino
white, 2) disease mechanisms via deep brain phenotyping, 3) translational clinical research – pharmacological
through the generation of potential subjects for clinical trials, 4) biomarkers & diagnosis via neuroimaging and
biofluid biomarkers, and 5) enabling infrastructure via our Resource Sharing Hub at
https://www.radc.rush.edu/.